SynG: a Music-Based Intervention for Alzheimer's and Mild Cognitive Impairment

Project Summary / Abstract
In this proposal, Oscilloscape, Inc (dba Oscillo Biosciences) seeks NIH-SBIR funding to develop and test
an innovative, wearable digital health device to help aging adults with Alzheimer’s Disease (AD) and
Mild Cognitive Impairment (MCI). The device delivers a digital therapy using music and synchronized
visual brain stimulation. The wearable device, herein referred to as SynG (“SynchronyGamma”) is based
on patented neural network technology that models the dynamics of rhythmic brain activity. SynG aims to
stimulate healthy brain rhythms via the process of neural entrainment. In clinical populations who have
disruptions in brain rhythms, e.g., patients with AD and MCI, we hypothesize that this technology can
effectively restore normal brain activity important for learning, memory, and cognition. Ongoing tests
using a prototype tabletop display, 1 hr/day for 8 weeks, are showing that daily use improves memory and
cognition relative to controls. Key outcomes of this project are 1) a wearable version of the device with
which dosage can be precisely controlled, and 2) an IRB-approved study to assess the level of dosage
necessary for a therapeutic neural response.
The SynG project has potential to help age-related cognitive impairments by creating a music-
based, digital health device that delivers rhythmic brain stimulation via music and synchronized
light. Neurodegenerative disorders are a rapidly growing public-health concern, with AD alone projected
to affect 13.8 million Americans in 2050. AD patients undergo gradual cognitive decline, with MCI being
an early stage of the disorder. During this progression, patients experience multiple pain-points, including
memory loss, executive function deficits, and depression. Early intervention in the MCI stage may reduce
or even reverse cognitive decline. While pharmacological interventions for AD have primarily targeted
biomarkers such as beta-amyloid (Aβ) plaques, these strategies have shown limited success in improving
clinical outcomes and they all have potentially serious side-effects. Thus, there is an urgent clinical need
to develop novel therapies for AD and MCI. Recent findings that relate neural entrainment to Aβ offer an
exciting avenue towards non-invasive sensory interventions. Our goal is to develop a scalable solution
that will enhance independence for aging populations with cognitive disorders. The therapy can be
delivered in the patient’s own home via a comfortable wearable device and takes 30-60 minutes daily. It
is effective, scalable, and non-invasive. It is well-tolerated and does not interact with most traditional
pharmaceuticals. The objective of this SBIR project is to create a wearable version of SynG that can be
tested for efficacy in a fully powered clinical trial on older adults with mild-to-moderate cognitive
impairment.

Public health relevance
Project Narrative Oscilloscape, Inc (dba Oscillo Biosciences) and Northeastern University propose to develop and test a wearable digital health device, called SynchronyGamma (SynG), to treat aging adults with Mild Cognitive Impairment (MCI) and Alzheimer’s disease (AD) using music and rhythmic visual stimulation. Successfully developing SynG would lead to an innovative, effective, low-cost, scalable, non-invasive digital health device for AD and MCI that capitalizes on intrinsically strong brain responses to music and employs cutting-edge research on rhythmic brain stimulation for treating AD.